Ceramide and Cell Metabolism: Defining the Role of Sphingolipids in Modulating Mitochondrial Bioenergetics of Chronic Lymphocytic Leukemia

Project Summary/Abstract
Chronic lymphocytic leukemia (CLL) is the most common form of adult leukemia and accounts for 20%
of leukemia-related deaths annually. In CLL, hyperactivation of the B-cell receptor (BCR) response leads to over-
activation of many downstream effectors that drive proliferation and survival, including Bruton’s Tyrosine Kinase
(BTK), LYN Kinase and the Signal Transducer and Activator of Transcription 3 (STAT3). This, along with
interactions with the microenvironment, leads to metabolic reprogramming and increased metabolic plasticity,
allowing CLL cells to thrive under various conditions. Our lab has previously shown that delivery of ceramide,
via a ceramide nanoliposome (CNL), targets this metabolic plasticity and disrupts the STAT3 signaling pathway,
leading to decreased transcriptional activity, impaired glycolysis and cell death in multiple CLL models, including
patient samples. However, restoration of glycolysis and/or STAT3 transcriptional activity only partially protects
from CNL-induced cell death, suggesting that other mechanisms are at play. Here, using an advanced
mitochondrial metabolomics workflow, I show that CNL disrupts oxidative phosphorylation (OXPHOS) by
selectively inhibiting Complex III of the electron transport chain. This disruption of OXPHOS is time dependent
and correlates with a CNL induced upregulation of glycosphingolipids in both whole cells and mitochondrial
extracts, suggesting an unexpected link. Importantly, while glycosphingolipids are typically seen as a protective
shunt away from more apoptotic ceramides, I have shown that inhibition of glucosylceramide (the gateway lipid
to the glycosphingolipid pathway) formation protects from CNL mediated mitochondrial dysfunction and cell
death in CLL, further supporting this connection. Lastly, glucosylceramide blockade also diminishes the ability of
CNL to alter LYN and BTK phosphorylation. Given these effects, I hypothesize that sialic acid containing
glycosphingolipids downstream of glucosylceramide activate SIGLECS (the sialic acid binding proteins known
to negatively regulate BCR signaling) leading to mitochondrial dysfunction and cell death. Insights into this area
will provide a novel therapeutic framework for CLL patients and deepen our understanding of lipid/protein biology.
The first aim of this proposal (F99 Phase) identifies the key glycosphingolipid metabolites driving these
effects, determines the mechanism by which they alter BCR signaling effectors and mitochondrial function, and
evaluates their therapeutic potential in vivo. The knowledge and skills learned from these studies will then be
used to study the role of lipid metabolism in the metabolic plasticity of glioma stem cells and in the mechanisms
governing mitochondrial transfer between these cells and astrocytes in the context of glioblastoma (K99 Phase).

Public health relevance
Project Narrative: Chronic Lymphocytic Leukemia (CLL), which remains incurable despite recent advances in targeted therapeutics, relies on metabolic alterations to meet the immense energetic demands of sustained growth and persist in diverse environments including the blood, spleen, lymph nodes and bone marrow. Sphingolipids, particularly ceramides, hold great therapeutic potential as they can regulate many cellular pathways that impinge on metabolic systems and the delivery of these bioactive molecules has been shown to induce cell death in both in vitro and in vivo models of CLL. The F99 phase of this proposal will establish the mechanism by which exogenous ceramide induced ganglioside accumulation leads to mitochondrial dysfunction and cell death in CLL, while the K00 phase will leverage CRISPR screening and advanced in vivo mitochondrial characterization to better understand the role of sphingolipids and their therapeutic potential in mitochondrial transfer and glioma stem cell support of glioblastoma.